Identifying Prevotella copri-mediated effects of dietary glycan supplementation on microbial community and host metabolism

ABSTRACT
Globally, undernutrition remains the largest source of mortality for children under five years of age.
Stunting (impaired linear growth) and wasting (low weight-for-height) respectively affect 148 and 45 million
children; both are associated with permanent sequelae, including impairments in immunity and
neurodevelopment and susceptibility to infection. While undernutrition is preventable, existing interventions fail
to prevent these long-term complications, highlighting the continuing need for treatment options.
Microbiota-directed complementary food (MDCF) formulations are novel therapeutic foods that were
designed to treat undernutrition by repairing delayed microbiota development observed in these children. A
clinical trial of Bangladeshi children with moderate acute malnutrition demonstrated that one formulation,
MDCF-2, improved weight gain compared to a standard nutritional intervention. Gnotobiotic animal studies
have implicated Prevotella copri, an organism which is prevalent in non-Western populations and encodes
diverse carbohydrate utilization machinery, in mediating beneficial effects of MDCF-2. In mice fed MDCF-2, P.
copri colonization promotes weight gain and degradation of arabinan, an abundant glycan in MDCF-2, and
shifted microbial community metabolism towards utilization of arabinose and amino acid synthesis.
However, it remains unknown whether P. copri mediates MDCF-2’s growth-promoting effects through
direct products of carbohydrate catabolism or other metabolic activities, and to what extent these effects
depend on interactions with other organisms. The central hypothesis of this proposal is that the growth-
promoting effects of MDCF-2 are mediated in part by other organisms which utilize arabinose liberated
by P. copri to synthesize tryptophan and indole derivatives. To test this hypothesis, the first aim of this
proposal will identify contributions of individual arabinose-utilizing organisms to differences in amino acid and
microbial metabolite levels that are observed with P. copri colonization. This will involve analysis of existing
metagenomic (MGX), metatranscriptomic (MTX), and mass-spectrometric datasets from mice colonized with
and without P. copri, as well as validation of cross-feeding by co-culturing of P. copri and arabinose-utilizing
organisms in vitro. Due to limitations of existing methods, this aim will also require development of new
statistical methods for differential expression analysis of paired MGX and MTX sequencing data. To test
whether dietary arabinan supplementation is sufficient to recapitulate the beneficial effects of MDCF-2, the
second aim will utilize gnotobiotic mouse models to assess the effects of arabinan on host weight gain,
intestinal gene expression, and microbial community composition and metabolism. Together, these studies will
reveal mechanisms by which active ingredients in MDCF-2 mediate its effects, informing future therapeutics for
undernutrition. They will also evolve methodology for deconvoluting functional activities of individual microbes
from complex community dynamics with numerous applications beyond childhood undernutrition.

Public health relevance
PROJECT NARRATIVE Despite nutritional and infrastructural interventions, childhood undernutrition remains a pervasive global health challenge and the leading cause of mortality in children under the age of five worldwide. This proposal aims to dissect the mechanisms by which Prevotella copri mediates beneficial weight gain achieved by a therapeutic food for treatment of childhood undernutrition, MDCF-2, by interrogating the organism’s role in altering microbial community tryptophan and indole metabolism and the ability of bioactive glycans in MDCF-2 to recapitulate its positive effects. These studies will not only elucidate mechanisms by which growth-associated organisms respond to MDCF-2’s bioactive ingredients with implications for future food and microbe-based therapeutics for childhood undernutrition, but will also advance methodology for deconvoluting the responses of individual microbes from within complex community dynamics with numerous applications beyond childhood undernutrition.